An investigation of transdiagnostic mechanisms underlying ASD and ADHD traits among infants at risk

PROJECT SUMMARY/ABSTRACT
By the time they are typically detected, attention-deficit/hyperactivity disorder (ADHD) and autism spectrum
disorder (ASD) are already challenging to treat. ADHD is characterized, in part, by deficits in self-regulation,
while social communication deficits are a hallmark of ASD. Although traditional diagnostic definitions imply
distinct phenotypes, co-occurrence is common with evidence of shared heritability, but little is known about
overlapping versus unique markers and mechanisms early in development. Putative shared processes include
dysregulation of attention and affect. Based on links with these processes, respiratory sinus arrhythmia (RSA),
an index of parasympathetic nervous system (PNS) functioning reflecting effort allocation and emotion
regulation, has been suggested as a potential transdiagnostic biomarker. No prior studies have examined shared
versus distinct contributions of atypical infant PNS functioning, attention regulation, and affect regulation to later
self-regulation and social communication deficits in infants at genetic risk for such challenges. Moreover, few
studies have characterized continuity of symptoms across early childhood in high-risk samples, nor have infant
predictors of symptom continuity been examined. Addressing these points is imperative to enhancing early
detection efforts, delineating mechanisms underlying symptom development, identifying targets and time points
for prevention and intervention, and determining novel markers of treatment efficacy. This proposal seeks to
better understand developmental pathways to the Research Domain Criteria (RDoC) domains of cognitive
systems (cognitive control/self-regulation) and social processes (social communication) across early
development in a sample enriched for such challenges: infants at familial risk for ASD (n = 60), familial risk for
ADHD (n = 60), and low risk for both (n = 40). We aim to: (1) identify shared and distinct early behavioral and
physiological markers of, and mechanisms underlying, self-regulation and social communication problems
among infants at risk, and (2) evaluate continuity of self-regulation and social communication problems across
early childhood, including delineation of infant predictors of such continuity. Leveraging previous NIH support
(K99/R00 MH106642) and employing a multi-method, multi-informant, multi-dimensional design, infants will be
evaluated at 6 or 9, 12, 18, 24, and 36 months of age with a focus on trajectories and mediational mechanisms.
This R01 proposal responds to the NIMH Strategic Plan to “Define the Mechanisms of Complex Behaviors” and
“Chart Mental Illness Trajectories to Determine When, Where, and How to Intervene.” Exploring shared versus
distinct mechanisms underlying the development of self-regulation and social communication symptoms will
improve early identification of disorders like ADHD and ASD and encourage the development of transdiagnostic,
process-focused early interventions, consistent with RDoC goals.

Public health relevance
PROJECT NARRATIVE This study, focused on infants at elevated risk for autism spectrum disorder (ASD) and attention- deficit/hyperactivity disorder (ADHD), will identify early markers of self-regulation and social communication symptoms across early development with a focus on attention regulation, emotion regulation, and psychophysiological indicators. It will also enhance our understanding of relationships between self-regulation and social communication problems over time. The goal is that this research will improve early identification of disorders like ADHD and ASD, and encourage the development of process-focused interventions that can be applied across a range of infants and toddlers at risk.